Admin Core - Autophagy Modulators as Novel Broad-Spectrum Anti-Infective Agents

Project Summary – Administrative Core
The Administrative Core will provide the requisite infrastructure to achieve the overall research objectives of the
CETR. Effective scientific management and coordination by the Administrative Core will provide direction,
oversight, and quality control for the research activities of each Project, and will maximize collaboration and
exchange from all participating groups. Clear scientific leadership and direct communication by the
Administrative Core will ensure optimal and transparent utilization of resources that promotes productive long-
term relationships. The Administrative Core will promote data sharing, integration of projects, and
communication, which will leverage the expertise of each member of the CETR to expedite discovery and
achievement of the research goals. The Administrative Core will achieve several of these goals by providing a
coherent stream of communication, which will begin by establishing monthly meetings between Program
participants under the guidance of the Program Director. These meetings will be held through video
teleconference and will promote data exchange, evaluation of progress and planning as it relates to the goals of
the program and aims of individual projects. Each meeting will include discussion and analysis of results, goals
and progress, as well as a forum for negotiation of key strategic decisions. The Administrative Core also will
foster communication and organizational structure through preparation of financial reports and documents (e.g.,
progress reports) for the NIH. The Administrative Core will have specific financial responsibilities and obligations
particularly as it relates to shared activities among CETR members. This will include costs associated with
Scientific Advisory Committee travel and clerical/communication programs directly related to the CETR. Through
these activities, the Administrative Core will ensure an interactive and collaborative environment, exchange of
reagents and data, and foster a cohesive relationship among PIs of the CETR, which will enhance our direct
goal of further developing novel autophagy-directed anti-infectives against NIAID priority pathogens.